Role of Macrophages in CBD mediated attenuation of SEB-induced ARDS

PROJECT SUMMARY/ABSTRACT
The virus, SARS-CoV-2 has caused COVID-19 and claimed the lives of over 240,000 Americans and
1,270,000 people worldwide. Severe cases of the disease leads to Acute Respiratory Distress
Syndrome (ARDS), sepsis and can be fatal due to pulmonary inflammation and destruction of the
epithelial and endothelial cell lining. Understanding the mechanisms behind these diseases is vital to
develop effective preventive and therapeutic strategies. Staphylococcus enterotoxin B (SEB)-induced
ARDS mimics the cytokine storm, sepsis and multiple organ failure presented in patients with severe
COVID-19. It has been shown that the superantigen structure and sequence associated with the spike
protein of the SARS-CoV-2 is similar to that of SEB. This SEB-induced ARDS model also results in
various presentations of severity of illness in mice of different genetic backgrounds, as does COVID-
19 in humans. When C3H/HeJ mice are treated with SEB, their survival rate drops to 0%. In our study,
we found that Cannabidiol (CBD) administration following SEB treatment, led to 100% survival
indefinitely. Initial evaluation of whole single cell sequencing data comparing lungs from naïve with
SEB-induced ARDS mice illustrated that there was an increase in neutrophils, inflammatory
macrophages and pro-inflammatory cytokines (IL-1β and TNF-α) as well as a loss in lung epithelial
cells. To characterize the mechanism by which CBD treatment led to amelioration of the inflammatory
response, microRNA expression analysis was done that showed a significant decrease in expression
of miR-124-3p in SEB-treated group which is directly associated with upregulation of TNF-α and IL-1β
expression as well as macrophage activation gene, Cebp. We hypothesized that CBD attenuates SEB-
induced ARDS by miRNA dysregulation in lung-infiltrating cells, specifically by inducing miR-124-3p
which downregulates Cebp expression resulting in reduced activation of macrophages. Aim 1 will
elucidate the role of resident and monocyte-derived macrophages in disease and the effect CBD on
those subpopulations. Aim 2 will elucidate whether CBD affects Cebp expression and the effects that
miR-124-3p has on manifestation of disease. Aim 3 will determine the epigenetic factors regulating
expression of miR-124-3p. This study will explore CBD as a potential therapeutic for ARDS and/or
sepsis induced not only by SEB but other pathogens such as SARS-CoV-2. The K99R00 will provide
opportunities associated with Career Development and training in –omics approaches and biostatistics.
Taken together, my mentors, advisory committee, consultant, and research environment at the
University of South Carolina will nurture my successful transition to an Independent Investigator.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health as it will study the mechanism by which Cannabidiol (CBD) ameliorates Acute Respiratory Distress Syndrome (ARDS). Elucidating the mechanism for a natural therapeutic to treat ARDS is vital to advance COVID-19 and Sepsis research.